Developmental Research Project Program

Modified Project Summary/Abstract Section

MONTANA INBRE DRPP SUMMARY
The overall goal of the MT INBRE V Developmental Research Project Program (DRPP) is to expand research capacity at all institutions in the statewide network. This will be facilitated by supporting and mentoring junior investigators in their establishment of biomedical and health science research programs. The overarching goals of MT INBRE V are to 1) expand the biomedical/health sciences research network and student pipeline in MT, and 2) improve the health of all Montanans through rigorous and ethical research. The Developmental Research Project Program (DRPP) is integral to our achievements and a driver of reaching the goals of the MT INBRE program. To achieve these goals, MT INBRE V will expand the interdisciplinary research capacity at partner institutions in the state. The DRPP is fully invested in the successful career trajectory of the investigators themselves, as well as in the development of a pipeline of students determined to have careers in biomedical research and healthcare. Three specific aims will guide program efforts. Specific Aim 1: Create an interdisciplinary biomedical research network and strengthen biomedical research expertise and infrastructure across Montana that is sustained outside of INBRE. Specific Aim 2: Build a strong workforce for conducting biomedical and health science research across Montana. Specific Aim 3: Establish a pipeline of students focused on biomedical research and healthcare careers.